A randomized trial of charcoal-filtered cigarettes on product perceptions, smoking behaviors, and toxicant exposure

PROJECT ABSTRACT
“Light” cigarettes were marketed by the tobacco industry – and perceived by consumers – as safer cigarettes
for decades before researchers determined that flaws in their filter design increased harm to their users,
illustrating the necessity of understanding how cigarette design and perceptions influence smoking behavior
and toxicant exposure. Cigarettes using charcoal filters (versus traditional cellulose acetate filters) have been
shown to reduce exposure to certain toxicants, but these findings are based on machine-generated estimates
of smoking behavior that previously failed to capture the compensatory smoking that occurred with actual
human use of “light” cigarettes. Thus, it is unknown if findings demonstrating potential benefits of using
charcoal-filtered cigarettes translate to real-world use of these products, given characteristics of the filter (e.g.,
design, type/amount of charcoal), potential for compensatory smoking, and/or limitations on charcoal’s
absorption abilities. Nevertheless, Santa Fe Natural Tobacco Company recently introduced a new charcoal-
filtered cigarette under its Natural American Spirit (NAS) brand called 'Sky' and has been promoting it implicitly
as a reduced harm product. Given NAS’s continued market growth while other brands are in decline, and a
general industry movement towards promoting various lower risk tobacco products, this action could
foreshadow greater industry interest in this type of product. Since other brands often mimic NAS’s marketing
tactics to promote sales, understanding consumer experiences with Sky could help predict its longer-term
commercial success and the likelihood of other companies introducing similar products. Given that use of
charcoal-filtered cigarettes is widespread in other countries, the need for ecologically valid research on their
use and effects on toxicant exposure, and NAS’s popularity with U.S. consumers, we seek to empirically
examine this novel product now, before it gains traction in the U.S. market. We will recruit 210 adults who
smoke cigarettes daily to complete a 5-week laboratory-based, open-label, parallel-design randomizing
participants, after a 1-week baseline period of smoking their preferred brand, to use one of three types of
cigarettes for a 4-week experimental period. Cigarette types are matched on key constituents and
characteristics, and will include two charcoal-filtered cigarette varieties (NAS Sky and Tareyton) and a control
non-charcoal cigarette (NAS Yellow). Participants will complete weekly sessions to assess primary outcomes
of: smoking behaviors (daily cigarette consumption, puffing behavior), product perceptions (subjective ratings,
perceptions of harm), and toxicant exposure (carbon monoxide levels, urinary biomarkers of nicotine, volatile
organic compounds, and tobacco-specific nitrosamine exposure, and charcoal granule release). Data acquired
from this project may be used to inform cancer prevention and control and/or tobacco regulatory efforts.

Public health relevance
PROJECT NARRATIVE Although charcoal-filtered cigarettes have potential to reduce exposure to tobacco-related toxicants, a new variety of this product was recently introduced to the U.S. market by a brand known for misleading consumers about the risks of its cigarettes. Rigorous, comprehensive behavioral and biological data are needed to characterize how charcoal-filtered cigarettes are perceived and smoked, as well as what type of toxicant exposures are associated with their use. The proposed research will be the first large, randomized behavioral study to address these issues; its findings may inform cancer prevention and control efforts and/or tobacco product regulation.